ADMINISTRATIVE

The Administrative Core will provide management services to each of the Projects and Cores in this Program. The Core will provide financial, adminstrative, and clerical services for the PI, the Co-Pi, Project Leaders, and Core Leaders for all grant-related activities. These activites include the preparation of this competing renewal, non-competing renewals including progress reports, preparation of budgets, communication with the NIH regarding renewals and all financial interactions, and assurance that the labs supported by this Program are in full compliance with all institutional, state and federal regulations. Core A will also coordinate and scheduling all meetings related to the function of the Program, including monthly meetings of all Project and Core Leaders, and members of their respective laboratories, as well as twice yearly meetings of the Internal and External Advisory Boards. Core A will also coordinate efforts with off-site investiators at the three neighboring institutions, Brigham and Women's Hospital, Beth Israel-Deaconess Hospital, and Children's Hospital of Boston, as well as interaction with the investigators at the DFCI. Dr. Gilliland is the PI and Director of this Core, and will serve as the overall scientific director and chief administrator. Dr. Griffin is the Co-Pi and will assist in these operations, particaulrly with regard to matters with the on-site investigators and clinical programs at the DFCI. He will assist Dr. Gilliland in monitoring protocol performance and will assist in protocol development. Alberto Jamarillo is a highly skilled administrator with experience in management of fiscal and administrative matters for large program project grants. He will serve as Administrative Facilitator, and coordinate Program administration and fiscal oversight with Dr. Gilliland and Dr. Griffin. Alberto Jamarillo will be assisted by Betsy Kelley, a Grants Management Specialist/Post Award, and Mariha Duarte, an administrative assistant, in coordination with Dr. Gilliland and Dr. Griffin, to manage budgets between participating institutions, prepare reports including noncompeting renewals, interface with the financial officers of each participating institution in the Program, and serve as an interface between these groups and the NIH. In addition, the Administrative Core will assure compliance with appropriate regulations regarding experimentation with human subjects, (including gender and minority participation) and vertebrate animals.